Integrative Health Sciences Core

Technical and substantive research support Is available to Center members through the Integrative Health Sciences Facility Core (IHSFC). The IHSFC goal is to encourage, support, and enhance Center environmental health sciences research in human populations.